EFFECT OF PHENYLPROPANOLAMINE ON THE PHARMACOKINETICS OF CAFFEINE

To evaluate the effect of phenylpropanolamine on the pharmacokinetics of caffeine disposition. To evaluate the effect of phenylpropanolamine on the renin, catecholamine and blood pressure responses to caffeine.